Emory Specialized Center of Research Excellence (SCORE) on Sex Differences

PROJECT SUMMARY / ABSTRACT (Leadership Administrative Core)
The mission of the Leadership Administrative Core (LAC) is to develop a community of women’s health and sex science that will transform Emory University into a Center of Excellence whose investigators routinely include sex as an essential variable in all areas and stages of research. The LAC is responsible for providing operational support, scientific and administrative leadership, education and community building, information dissemination and outreach, and monitoring and evaluation activities for the SCORE. In the Emory SCORE’s inaugural funding cycle, the LAC supported a network of sex scientists and promoted successful synergies between the SCORE and Emory’s wealth of existing programs that support women’s health and infectious diseases research, including the MACS/WIHS Combined Cohort study within which the SCORE’s research cohort of women living with and at-risk for HIV is nested. In the next project period, the LAC will 1) Provide administrative and operational support for the SCORE at Emory University; 2) Furnish SCORE Cores and Projects with resources necessary to complete their aims; and 3) Foster information sharing about sex science among researchers and the larger community.
Through a multi-faceted annual strategic planning process, the LAC will continually evaluate SCORE services and leverage University resources to meet the evolving needs of women’s health and sex science researchers at Emory (AIM 1). When developing the SCORE strategic plan and evaluating SCORE activities, the LAC will receive guidance from three advisory groups, including the SCORE internal and external advisory boards and the SCORE Community Liaison Council. Further, the LAC will provide budgetary support for the three interlinked research projects (“Bone, Brain, Heart”) and work with the Career Enhancement Core (CEC) and Biostatistics and Bioinformatics Core (BBRC) to support research funding, training, mentoring, and professional development activities (AIM 2). The LAC will disseminate information about sex science (AIM 3) through career development initiatives, including an annual International SABV Workshop, and engage multiple channels of outreach with the SCORE! Newsletter, social media, and the Community Liaison Council. Members of the LAC leadership team have a long history of collaboration and will work together to enable, amplify, and disseminate SCORE’s research, education, and training activities. The success of the LAC is grounded in the formidable institutional, environment, and leadership support provided by Emory University and its faculty.

Public health relevance
PROJECT NARRATIVE: LEADERSHIP ADMINISTRATIVE CORE The Leadership Administrative Core (LAC) is the coordinating hub of the Emory Specialized Center of Research Excellence in Sex Differences (Emory SCORE). The goals of the LAC are to provide creative leadership to the Cores and Projects, allocate resources in support of the SCORE’s programmatic and scientific aims, manage activities and services, continuously evaluate progress toward achieving our mission, develop the next generation of diverse women’s health and sex investigators, and promote the continued normalization of the inclusion of sex as a biological variable (SABV) in research at Emory University and beyond.